Type 2 diabetes risk variant effects on mitochondrial (patho)physiology

PROJECT SUMMARY / ABSTRACT
Type 2 diabetes (T2D) results when pancreatic islet β-cells fail to secrete sufficient insulin to meet peripheral
insulin demand. Mitochondrial bioenergetics is central to the (patho)physiology of β-cell (dys)function, and recent
work suggests that β-cell mitochondrial dysfunction precedes the development of T2D in β-cells from donors
with impaired glucose tolerance (or pre-diabetes). Mitochondrial defects have been reported in the β-cells of
human T2D patients, but the etiology of mitochondrial dysfunction in T2D is unknown. Such mechanistic
knowledge is necessary to guide strategies to prevent or treat islet failure and T2D. Importantly, genome-wide
association studies (GWAS) link single nucleotide polymorphisms (SNPs) in >500 genetic loci to T2D and islet
dysfunction-related metabolic traits. The majority of these SNPs are non-coding and overlap regulatory elements
(REs) with broad transcriptional implications for affected cells. In this study, we combine our expertise in the
genomics of T2D, (epi)genomic modification, and mitochondrial function in β-cells to bridge the gap from genomic
association to mechanistic understanding. We hypothesize that non-coding T2D SNPs cause β-cell dysfunction
by altering RE use or activity, thereby changing expression of effector genes that directly impair mitochondrial
health. To test this, we propose to use sophisticated (epi)genomic editing tools in human islets and β-cell specific
mouse models for physiological relevance and validation in two complementary Aims. In Aim 1, we will test RE–
effector gene links in human islets using CRISPR-QTL. In parallel, we will assess T2D risk allele effects on RE
chromatin accessibility, activity, transcription factor binding, and β-cell expression of putative mitochondrial T2D
effector genes using complementary in vivo (single cell chromatin accessibility, histone acetylation, and
expression quantitative trait locus analysis of primary human islets) and in vitro (reporter gene, DNA-binding
assay) approaches. Finally, we will determine the consequences of effector gene perturbation on mitochondrial
phenotypes, β-cell viability, and insulin content and secretion in human islets and EndoC-βH3 cells. In Aim 2,
we harness β-cell-specific knockout mouse models to assign function to two high-priority mitochondrial T2D
effector genes in glycemic control, β-cell mass/function, and mitochondrial metabolism. Further, we will address
the importance of these mitochondrial T2D effector genes for β-cell compensation to peripheral insulin resistance
following diet-induced obesity. Finally, we will use (epi)genomic editing tools in human islets to determine if
mitochondrial T2D effector genes impair β-cell function and glycemic control in ex vivo assays as well as after
islet transplantation into immunodeficient mice. Completion of this study will generate new variant-to-function
connections that assign molecular and cellular functions to T2D risk alleles, identify novel therapeutic targets,
and provide important knowledge to guide subsequent strategies to prevent or treat β-cell failure and T2D.

Public health relevance
PROJECT NARRATIVE Type 2 diabetes (T2D) is a complex genetic disease that places substantial burden on the medical and public health systems. We have identified a set of genomic DNA sequence changes in people with T2D that we hypothesize contribute to this disease by changing gene expression patterns and reducing the ability of mitochondria to function in islet cells of the pancreas. In this project, we will complete innovative genomic and cellular analyses, including techniques to 'edit' these genomic DNA sequences, in human islet cells and preclinical mouse models of T2D to test our hypothesis and determine how a targeted subset of genes regulating mitochondrial function contribute to T2D genetic risk and progression.